Regulation of transcriptional activation by protein disorder

Regulation of transcriptional activation by protein disorder
PIs: Daughdrill/Chen
Abstract
The p53 tumor suppressor is a sequence-specific DNA binding protein that activates gene transcription
to regulate cell survival and proliferation. It is mutated in at least 50% of solid tumors and some of these
mutants are oncogenic and activate the transcription of genes that promote cell survival and metastasis.
Despite decades of research on p53, there are currently no FDA approved drugs in the clinic that directly
target wt or mutant p53. This is, in part, because 50% of p53 is disordered and we have an incomplete
understanding of what these regions look like and how they function. We have recently shown that the
disordered N-terminal acidic transactivation domain of p53 (NT) dynamically interacts with the DNA
binding domain (DBD) with residues that contact DNA. This interaction inhibits DNA binding but
increases binding specificity using a combination of nucleic acid mimicry and electrostatic shielding that
enhances recognition of promoter binding sites in vivo. We propose to: (1) Determine the specific effects
of nucleic acid mimicry and electrostatic shielding on DNA binding specificity, and how tethering controls
the intramolecular interaction between NT and DBD. (2) Investigate how p53 NT phosphorylation
regulates DNA binding affinity and specificity to create adaptable switching of transcriptional activation.
(3) Determine how MdmX interferes with p53 DNA binding when it forms a heterodimer with p53.
Successful completion of these experiments will lead to a better understanding of how p53 governs cell
fate after DNA damage by regulating the binding specificity to pro-survival versus pro-apoptotic target
genes. A deeper understanding of the structural and functional properties of the weak dynamic
interactions within p53 and between p53 and MdmX is necessary for the successful development of
small molecules to target these interactions for cancer therapy.

Public health relevance
Regulation of transcriptional activation by protein disorder PI’s Daughdrill/Chen Narrative The p53 tumor suppressor is a sequence-specific DNA binding protein that activates gene transcription to regulate cell survival and proliferation. Despite decades of research on p53, there are currently no approved drugs that specifically target wt or mutant p53 in cancer. This is, in part, because 50% of p53 is disordered and we have an incomplete understanding of what these regions look like and how they function. This proposal will investigate how the p53 N terminus interacts with the DNA binding domain, regulate DNA binding affinity, and activation of target genes. The role of p53 N terminal phosphorylation on p53 intramolecular interaction and DNA binding specificity will be investigated. We will also determine how MdmX inhibits p53 DNA binding, mediated by the interaction of MdmX linker sequence with the DNA binding domain. Successful completion of the proposed experiments will determine how the disordered regions of p53 and MdmX dynamically interact through intra- and intermolecular contacts to control DNA binding specificity and activate target gene expression.